Developing a Multi-Organ Multi-Omics Computational Framework for StudyingMammalian Iron Systems Biology

PROJECT SUMMARY/ABSTRACT
Iron disorders are caused by changes in iron levels in blood, tissues, or both. Iron deficiency, which can lead to
anemia, represents a major component of the global disease burden worldwide, especially in women. Iron
deficiency-related anemia affects >1.2 billion individuals worldwide, and iron deficiency without anemia is even
more frequent. Understanding the basic molecular mechanisms underlying specific iron disorders is critical to
designing future therapeutic strategies. Approaches using iron supplementation or iron chelators are employed
globally to improve iron metabolism. However, their effectiveness can vary among patients due to the diverse
mechanisms underlying iron disorders. Some etiologies are linked to impaired iron absorption in the intestine,
while others involve issues with iron delivery to the bone marrow, which is crucial for sustaining erythropoiesis.
The goal of my program at The Jackson Laboratory is to identify the root causes of iron disorders, including iron
deficiency, iron deficiency anemia, anemia, and/or iron overload, by holistically investigating the fundamental
biological mechanisms of iron metabolism. By focusing on the etiology of these disorders rather than merely
addressing the symptoms, we aim to facilitate personalized medicine tailored to each patient’s specific needs.
During the next five years, the AgoroLab will develop a novel computational framework, the Multi-Omics-Multi-
Organ sequencing (MOMO-seq), for studying mammalian iron systems biology in different tissues associated
with iron metabolism phenotypes and identify key organs, cells, and molecular features that drive iron disorders.
MOMO-seq couples the power of single-cell multi-omics technology to profile DNA accessibility with
transcriptomics/histopathology approaches to study iron biology across multiorgan systems, enabling the
identification of cell-specific mechanisms and inter-organ communication circuits associated with iron
metabolism. Within our framework, we will be able to shed light on some of the key yet unanswered questions
in iron biology. This includes deconvoluting the complex multiorgan signaling network that maintains iron
homeostasis. For instance, how does the bone marrow communicate with the spleen to meet the high iron
demand of erythropoiesis? How do kidneys regulate iron reabsorption? Developing MOMO-seq will be pivotal in
establishing and strengthening my independent research program, as well as laying the groundwork for an
innovative, comprehensive approach to studying iron metabolism and its implications in health and disease.

Public health relevance
PROJECT NARRATIVE Iron deficiency-related anemia affects >1.2 billion individuals worldwide, and iron deficiency without anemia is even more frequent. Our laboratory aims will investigate the etiology of iron disorders by developing a new computational approach that allows the integrative study of iron metabolism across multiple tissues simultaneously. We believe this approach will be crucial in facilitating personalized medicine tailored to each patient’s specific needs.